Administration and Management

Project Summary The Administration of the Yeast Resource Center will build on strategies learned and used by the center over the last 20 years of funding in the successful management of a Biomedical Technology Research Resource. The greatest strength of our center is a highly experienced and diverse team of investigators that have worked together for a very long time. Our close and effective working relationship is evident by our long and productive resource. Our center is unique amongst the NIGMS Biotechnology Research Resources in that, unlike many other centers that focus on a single technology, our resource leverages an experimental system using many technologies to drive biomedical research. We will continue to use the administrative capabilities we have put in place over the last two decades to ensure an effective and functioning resource for the scientific community.